Defining the role of Pi16-expressing fibroblasts in mouse and human fibrosing skin disease

PROJECT SUMMARY/ABSTRACT
This proposal describes a 5-year research and career development plan that will enable Dr. Maxime Kinet to
achieve his long-term goal of becoming an independently funded physician-scientist studying how different
fibroblast subsets contribute to tissue homeostasis and fibrosing diseases. Currently, very little is known about
how individual fibroblast subsets, identifiable in healthy tissues, differ in their responses and contribution to
fibrosing skin disease. The proposed research will focus on uncovering the mechanisms by which the Pi16+
fibroblast subset, common to many organs in mammals, responds to and reduces fibrosis. Dr. Kinet will use a
novel, fibroblast-subset-specific Pi16CreERT2 line to study this conserved subset. Additionally, he will apply this
Cre line alongside a highly innovative in vivo CRISPR/Cas9 technique to enable interrogation of any genetic
pathway in these cells. In Aim 1, Dr. Kinet will elucidate how Pi16-expressing fibroblasts molecularly respond
to a fibrotic stimulus. Aim 2 will focus the mechanisms used by Pi16-expressing fibroblasts to reduce fibrosis in
the overlying skin. In Aim 3, Dr. Kinet will leverage comprehensive single-nuclear and spatial transcriptomic
technologies to identify how Pi16-expressing fibroblasts change in human fibrosing skin disease. The
aggregate data will provide a major advancement in our understanding of how Pi16-expressing fibroblasts, a
conserved subset across tissues and species, respond to and regulate fibrosis.
During his post-doctoral work and as Assistant Professor in the University of California, San Francisco (UCSF)
Rheumatology Division, Dr. Kinet has strategically sought out additional training and mentorship in cutaneous
immunology and fibrosis. Under the primary mentorship of Dr. Michael Rosenblum, an expert in skin Treg
biology, the candidate, co-mentors Drs. Dean Sheppard and Ari Molosky, and scientific advisors Drs. Julie
Zikherman and Francesco Boin have developed a career development plan for Dr. Kinet to gain additional
experience in state-of-the-art immunology and cutting-edge transcriptomic profiling, biostatistics, and scientific
communication. To enhance Dr. Kinet’s training, a multidisciplinary advisory committee consisting of mentors
and scientific advisors will meet biannually to review his progress and support his career development. The
proposed training program draws on the combined resources of the Rosenblum Laboratory, the UCSF
Immunology Training Program, and the UCSF Departments of Dermatology and Pathology. This will provide
an ideal setting for Dr. Kinet’s transition to an independent investigator.

Public health relevance
PROJECT NARRATIVE The skin is a critical organ that functions in somatosensation, protection against pathogens, temperature regulation, and cushioning of underlying organs and tissue, among necessary everyday functions. These functions and more can be impaired in fibroinflammatory diseases of the skin such as scleroderma and eosinophilic fasciitis. Our research focuses on how immune and non-immune cell types in the skin collaborate in health and fibrosing skin diseases.